Functional Roles of Retinal Gap Junctions in Visual Processing

DESCRIPTION (provided by applicant): Electrical synaptic transmission via gap junctions (gjs) is an important mode of neuronal communication in the CNS. An elegant example is the retina in which each of the five main neuronal types is electrically coupled via gjs. The broad distribution, structure, and regulation of retinal gjs suggest a diversity of functional roles in vsual processing; elucidating these roles forms the long-term goal of our experimental program. Here we propose to study the gjs in the inner mouse retina, which subserve a rich and complex variety of electrical circuits. The first aim of this proposal is to determine the role of gjs in creating the robust, correlated activity displayed by ganglion cells. Correlated ganglion cell activity is believed to have a number of functions, including enhancement of signal saliency and encoding of specific information about visual stimuli such as intensity, size, and motion. It is presently unclear whether concerted ganglion cell activity reflects common excitatory inputs via chemical synapses and/or gj-mediated electrical coupling between ganglion cells and their neighbors. We propose a multidisciplinary approach combining electrophysiological, pharmacological, and optogenetic techniques applied to transgenic and knockout mouse lines to differentiate the circuits responsible for correlated ganglion cell activity. The second aim will focus on concerted activity of ganglion cells separated over long distances and its role in encoding global visual information pertinent to perceptual grouping and object recognition. We will test the hypothesis that such long-range concerted activity is generated by wide-field amacrine cells that form gjs with ganglion cells separated by at least 750 μm. We will test whether deletion of gjs between ganglion and amacrine cells abolishes the concerted activity evokes by contiguous stimuli thereby producing a behavioral dysfunction rendering animals less capable of discriminating large, contiguous objects from two discrete objects. In the third aim we will study the novel idea the ganglion cells can alter intraretinal activity by signaling back to amacrine cells through interconnecting gjs. We posit that ganglion cells can alter the activity of coupled amacrine cell neighbors, which, in turn, inhibit other ganglion cells via conventional chemical synapses. This form of intraretinal signaling by ganglion cells creates a circuit providing a novel form of lateral inhibition. In the final aim, we propose to combine labeling with the gj-permeant dyes Po-, Pro-1, and Neurobiotin to provide a complete description of the different gj-mediated electrical circuits in the inner mouse retina that help produce the responses of the >20 different ganglion cell subtypes, which are transmitted to the brain. Deficits in gj communication have been implicated in a number of brain neuropathies, including visual impairments associated with retinitis pigmentosa, glaucoma and ischemic retinopathy. The experimental program proposed here will extend our understanding of the distribution and physiological roles of gjs, which form important prerequisites for determining how gj dysfunction affects neural function so as to suggest novel targets for the treatment for human disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: As the most important sense in humans, vision is the modality through which we interact mainly with the world around us. Gap junction dysfunction has been associated with a number of neurological defects related to vision, including retinitis pigmentosa, ischemic retinopathy, and glaucoma. The experimental program proposed here will extend our understanding of the distribution and physiological roles of gap junctions, which is fundamental to understanding how gap junction dysfunction affects retinal activity, so as to suggest novel treatments for human disease.